Confocal microscope for a live cell imaging facility at biosafety level 2

PROJECT SUMMARY
We are requesting a Leica STELLARIS 8 FALCON laser scanning confocal microscope for the microscopy facility
in the Department of Molecular Microbiology and Immunology at the Johns Hopkins Bloomberg School of Public
Health, which is part of the Johns Hopkins Medical Campus. A unique feature of our facility is the ability to perform
live cell imaging experiments with biological agents that require Biosafety level 2 (BSL-2) containment, including
human pathogens, such as Influenza A virus, Cryptococcus neoformans, Borrelia burgdorferi, Listeria
monocytogenes, Plasmodium falciparum and Toxoplasma gondii. The proposed instrument will represent the
first confocal microscope for this facility and within the current space restrictions will be singularly capable of
supporting the various advanced confocal microscopy needs of our users. Notable features that convinced us
during testing are its Wight Light Laser, translating into 350 laser lines, its imaging speed and the capacity to
detect up to five different fluorophores simultaneously, while offering the gentle imaging conditions needed for
live microscopy at confocal resolution. TauSense and FALCON enable the harnessing of fluorescence lifetime-
based information and with this provide additional image quality, the ability to separate overlapping fluorophores
and state-of-the-art measurements of protein interactions via FLIM-FRET. Altogether, the addition of this
instrument to our facility will significantly enhance NIH-funded projects of our users and greatly contribute to the
infectious disease focus and other key research areas of our institution.

Public health relevance
PROJECT NARRATIVE We are requesting a laser scanning confocal microscope for a microscopy facility that operates at Biosafety level 2 containment, for live cell imaging of samples containing human pathogens and/or potentially infectious biological agents. Located at the Johns Hopkins Bloomberg School of Public Health our projects include work with microbial pathogens that cause Lyme disease, Influenza, Malaria, cryptococcosis, toxoplasmosis and listeriosis disease. The requested instrument would significantly enhance a wide variety of studies that are relevant for the advancement of public health.